Improving Posthospital Medication Management of Older Adults Through Health IT

Abstract Improving Posthospital Medication Management of Older Adults through Health IT The incidence of drug-induced injury is high in the ambulatory geriatric population and is increased for elders upon transition from the hospital to the ambulatory setting. In this application, we describe an effort to build on our extensive experience in medication safety and HIT-based medication management to respond to the AHRQ RFA entitled Ambulatory Safety and Quality Program: Improving Quality through Clinician Use of Health IT (RFA-HS-07-006). In this study, we propose to develop and evaluate the value of an enhanced, HIT-based medication reconciliation system superimposed on the ambulatory electronic medical record (EMR) to improve the quality and safety of medication management, focusing particularly on the transition from the inpatient to the ambulatory setting for older adults with multiple comorbid conditions who are prescribed high risk medications. We propose a randomized controlled trial of a HIT-based transitional care intervention with enhanced medication reconciliation and therapeutic monitoring alerts to improve the quality and safety of patient monitoring and medication management. We postulate that the efficient and coordinated delivery of actionable health information to the clinician via use of HIT in the ambulatory setting can improve medication safety for the growing geriatric population. The specific aims for this study are to evaluate, among a population of older adults discharged from the hospital, the impact of an enhanced medication reconciliation system initiated upon transition to the ambulatory setting: (1) on the rate of follow-up by an outpatient provider within 14 days of hospital discharge;(2) on the prevalence of appropriate monitoring for selected high risk medications at 30 days from the time of hospital discharge;(3) on the incidence of adverse drug events (ADEs) 30 days after discharge;and (4) on the rate of emergency department visits and hospital readmission within 30 days of discharge. A secondary aim for this study is to determine costs directly related to the development and installation of the HIT-based transitional care intervention. This research allows for the examination of an integrated HIT intervention on the quality of follow-up, outpatient clinician workflow, occurrence of ADEs, and health care utilization to gain insights into the effective use of clinical alerts and coordinated delivery of actionable information to outpatient clinicians in the management of ambulatory elderly patients subsequent to hospital discharge. Project Narrative Improving Posthospital Medication Management of Older Adults through Health IT Older adults in the United States experience over 13 million hospitalizations per year and are at risk for almost 2 million drug-related injuries after discharge. The efficient and coordinated delivery of health information from the inpatient to the outpatient physician can improve the quality and safety of patient monitoring and medication management. We propose a randomized controlled trial to evaluate a health information technology (HIT)-based transitional care intervention with enhanced medication reconciliation and monitoring alerts to improve medication safety for the growing geriatric population.